Characterization of the oncogenic potential of circRNAs in melanoma

SUMMARY
Over the last decade noncoding RNAs (ncRNAs) have emerged as prominent players that are involved in the
regulation of most, if not all, biological processes. Given their important roles, it is conceivable that ncRNAs
contribute to the development of diseases such as cancer. Circular RNAs (circRNAs) are ncRNAs that are
formed through alternative splicing of linear pre-mRNAs via a process termed backsplicing. circRNAs are
abundant, stable, and evolutionarily conserved and display cell-type specific expression patterns, indicating that
they may play important roles in cell homeostasis, differentiation, development, and disease. However, the
formation of circRNAs, their regulation, and their functions are poorly understood, partially due to the lack of tools
to drive permanent ectopic expression of circRNAs. We have developed genetic tools for stable overexpression
of candidate circRNAs in vitro and in vivo, which we will implement as part of this R21 proposal. Using these
tools, we will determine the oncogenic potential of two circRNAs we hypothesize to promote melanomagenesis.
We identified circPMS1 and circDNAJC2 as candidate melanoma oncogenes by a comprehensive circRNA
expression analysis in benign melanocytes and malignant melanoma cells. We will test if overexpression of these
circDNAs promotes melanocyte transformation in vitro and tumor formation in our high-throughput melanoma
mouse models. We will also begin the molecular characterization of the functions underlying circPMS1 and
circDNAJC2 oncogenic activity, with an emphasis on peptide translation and miRNA sponging. Moreover, we
will specifically silence circPMS1 and circDNAJC2 in human melanoma cells in vitro as well as in xenograft
models to examine if circRNA expression is required for maintaining the transformed state and continued
melanoma growth, respectively. Our proposed studies will demonstrate that overexpression of circPMS1 or
circDNAJC2 drives melanomagenesis and establish an easily adaptable experimental framework that will pave
the way for future studies of oncogenic circRNAs.

Public health relevance
NARRATIVE The functions of circular RNAs (circRNAs) - abundant, stable, and evolutionarily conserved non-coding RNAs - in cancer are largely unknown, in part due to the inability to permanently overexpress circRNAs. We have developed genetic tools enabling stable ectopic circRNA expression in vitro and in vivo. By combining these overexpression tools with silencing approaches, we will analyze the oncogenic potential of circPMS1 and circDNAJC2, two circRNAs we identified as candidate onco-RNAs in melanoma.